A Human iPSC-Based Chimeric Mouse Model of Alzheimers Disease in Down Syndrome

Project Summary
The goal of our study is to better understand the pathogenic role of human microglia in Alzheimer’s disease (AD)
in Down syndrome (DS) and develop new therapeutic avenues for the treatment of AD in DS as well as AD in
general population. Our studies are in line with the goals of RFA-OD-20-005 because we will focus on evaluating
the genetic factors associated with trisomy 21 and their impacts on neurodegeneration using human tissue and
a novel human-mouse chimeric brain model and we will also use gene editing to remove triplicated genes. The
foundation of our studies is that recent genome-wide association studies have shown that many AD risk genes
are highly and sometimes exclusively expressed by the brain-resident macrophage, microglia. Recent
transcriptomic studies have also clearly demonstrated that human vs. mouse microglia exhibit distinct gene
expression profiles, and more importantly, they age differently under both normal and diseased conditions. These
findings argue for the utilization of species-specific research tools to investigate microglial functions in human
brain aging and degeneration. We propose to use a novel human induced pluripotent stem cell (hiPSC)-based
microglial chimeric mouse model that can recapitulate features of adult and aging human microglia to investigate
the role of human microglia in AD in DS. While the aggregation of amyloid-beta (Ab) precedes that of tau, tau
protein pathology commences in humans much sooner than was previously thought. Contrary to the marked
microglial activation reported in amyloidogenic transgenic mouse models, in human brain tissue derived from
AD and DS patients, brain regions particularly relevant in AD development, such as the hippocampal formation,
exhibit low and late Ab pathology, whereas hyperphosphorylated tau (p-tau) accumulates starting in the early
stages of the disease. The preferential accumulation of p-tau over Ab plaques could induce a totally different
microglial response. Here we put forward a new tau/microglial senescence hypothesis that human microglial
senescence and functional changes, induced by soluble p-tau, likely occur prior to neurodegeneration and is
causatively linked to the AD progression and cognitive decline in DS. We have created control and DS microglial
mouse chimeras by engrafting control and DS hiPSC-derived microglia into mouse brains. We will characterize
the dynamic responses of DS and control hiPSC-derived microglia to pathological soluble p-tau in human
microglial chimeric mouse brains, by using newly invented robotic four-dimensional long-term imaging
technology. We will determine the changes in synaptic functions by electrophysiological recordings and
behavioral performance of DS microglial chimeras after exposure to pathological soluble p-tau, as compared to
control microglial chimeras. Moreover, single-cell RNA-sequencing analysis of chimeric mouse brains and
CRISPR/Cas9-mediated removal of triplicated genes will be performed to determine the molecular mechanisms
underlying the pathogenic role of microglia. By understanding the underpinning mechanisms, we can develop
new therapeutic strategies to prevent human microglial senescence to slow the progression of AD in DS.

Public health relevance
Project Narrative: Down syndrome (DS), caused by triplication of human chromosome 21, is the single most common risk factor for Alzheimer’s disease (AD) and people with DS typically develop early-onset AD and dementia by their 60s. Here, we propose to employ a novel human microglial chimeric mouse brain model that is created by transplantation of human DS induced pluripotent stem cell-derived microglia to study the role of human microglia in AD/DS in vivo. Results from this study will help us better understand the mechanisms underlying the AD in DS and may steer AD therapeutic interventions into a new direction of aiming at preventing microglial senescence or rejuvenating microglia.